Investigator Development Core

PROJECT SUMMARY/ABSTRACT (IDC)
Tuskegee University Center for Biomedical Research (CBR) Research Centers at Minority Institutions
(RCMI) proposes the Investigator Development Core (IDC) to accelerate its past achievements in
enhancing the professional development and success of junior faculty supported by the program.
Towards this goal, it will provide junior-level and early-stage investigators at Tuskegee University (TU)
with the necessary resources and training to assist them in their move to the status of independent
researchers, with primary focus on the topics of minority health and health disparities. The IDC is
intended to support primarily: 1) Faculty members who are already in the field of biomedical research
but, because of their junior status, require a period of mentored career development in order to become
independent scientists in the fields of minority health and health disparities research; 2) Faculty who are
considered early-stage investigators in either non-biomedical or biomedical field, and interested in
minority health research or the translation of their existing research to the topics of minority health; and
3) Researchers who propose an approach that will have a substantial impact on the health outcomes in
the Black Belt Counties of Alabama.
More specifically, IDC aims to: 1) Provide funding for pilot research projects from junior level
or early-stage faculty who propose projects that address minority health and health disparities or
enhance TU research capacity, 2) Coordinate and facilitate mentorship, training, and professional
developmental activities for pilot project investigators and other TU faculty with potential to initiate
minority health projects, and 3) Establish broader affiliation of TU faculty with the CBR and engage
them in Center activities to create awareness and to promote greater participation in the overall aims of
the CBR/RCMI.
To achieve these aims, the IDC will coordinate and integrate its efforts with the Administrative
Core, the Capacity Building Core, the Community Engagement Core, our existing extramural
collaborative networks and the CBR program evaluation system. Multiple internal and external resources
will be leveraged and synergized to develop a broad-based investigator pool to grow biomedical
research at TU to even higher levels. The IDC support is expected to advance the professional growth
of junior faculty at TU by enhancing their productivity, competitiveness, and potential to be established
researchers on diseases that disproportionately impact minority populations.